Elucidation and therapeutic exploitation of PAK mediated radioresistance

PROJECT SUMMARY/ABSTRACT
Tumor resistance to radiotherapy remains a critical barrier to improving outcomes for patients diagnosed with
locally advanced, unresectable cancers. Cellular sensitivity to ionizing radiation (IR) is governed by intracellular
and extracellular factors. To overcome tumor radioresistance, drugs that sensitize tumor cells to ionizing
radiation (IR) are used. Non-targeted cytotoxic chemotherapies given concurrently with radiotherapy have
demonstrated improved tumor control and overall survival in cancer patients. However, since this paradigm
shifting approach occurred in the 1980's there has been a shocking lack of progress in developing molecularly
targeted radiosensitization approaches. Improving the therapeutic ratio of IR in combination with systemically
delivered drugs can be achieved by two general approaches, 1) using drugs that block DNA damage repair
responses 2) delivering radiosensitizing drugs selectively to tumors. These two methods are orthogonal
techniques to achieve the same end goal of increasing IR induced tumor kill while reducing normal tissue
toxicities. To address both of these fundamental cancer therapy problems, we have focused on target
discovery and tumor selective drug delivery vehicles. With regards to target discovery, our recent studies on
non-canonical CRAF functions led to our discovery of an unexpected role for PAK in DNA damage repair and
sensitivity to IR. PAK is comprised of a family of six kinases subdivided in Group I and II. Importantly, PAK are
involved in process central to oncogenesis, tumor aggressiveness and patient survival. To tackle tumor
selective drug delivery, we are developing drug conjugated activatable cell penetrating peptides (ACPP) to
selectively deliver potent radiosensitizers to tumors based on extracellular tumor protease activity. ACPP
consist of a drug conjugated polycationic cell penetrating peptide and an autoinhibitory polyanionic peptide
separated from each other by a flexible peptide linker. This peptide linker is specifically cleaved by proteases
enriched in the extracellular tumor microenvironment. While ACPP is intact, the drug conjugated cell
penetrating peptide is neutralized (i.e. held in a “pro-drug” state) by the polyanionic peptide so that the drug
cannot gain access to its intracellular target. Tumor microenvironment proteases cleave ACPP and release the
drug conjugated cell penetrating peptide, which is then taken up by tumor cells. The goals of our proposal are
to gain insight into how PAK governs radioresistance and then therapeutically exploit this with targeted PAK
inhibitors. In Aim 1, we will genetically determine the mechanisms through which Group I and II PAKs govern
IR resistance. In Aim 2, we will pharmacologically test the ability to radiosensitize tumors with small molecule
PAK inhibitors. In Aim 3, we will test if tumor targeted ACPP increase the therapeutic ratio of conjugated PAK
inhibitors. Our approach has complementary innovations in both DNA damage target discovery and tumor
selective drug delivery. Combining these approaches will lay a foundation for moving away from non-targeted
cytotoxic radiosensitization to biomarker driven molecularly guided radiosensitization.

Public health relevance
PROJECT NARRATIVE Understanding how tumors respond to radiotherapy is critical to producing new molecularly targeted treatments that overcome radiation resistance and improve survival for cancer patients. Based on our preliminary data, we predict that p21 activated kinases cause resistance to radiotherapy and that by targeting these kinases we can sensitize tumors to radiotherapy. In this proposal, we will investigate the mechanisms though which p21 activated kinases produce resistance to radiotherapy which will allow us to develop biomarker driven treatment approaches to increase radiotherapy's ability to destroy tumors while decreasing side effects.